Core: Biostatistics and Quantitative Methods Shared Resource

BIOSTATISTICS AND QUANTITATIVE METHODS SHARED RESOURCE
SUMMARY
The primary goal of the South Carolina Cancer Disparities Research Center (SC CADRE) Biostatistics and
Quantitative Methods Shared Resource is to expand the biostatistical and quantitative methods infrastructure
at South Carolina State University (SCSU) to sustain a long-term commitment to cancer research. This new
Shared Resource aims to provide outstanding biostatistics leadership and support in a cost-effective manner
for the SC CADRE and has been developed jointly by SCSU and the Medical University of South Carolina
Hollings Cancer Center (MUSC-HCC). The Biostatistics and Quantitative Methods Shared Resource will
provide biostatistical and bioinformatics support for the initial SC CADRE research projects as well as for
subsequent research initiatives led by SC CADRE investigators. This Shared Resource will also provide
ongoing quantitative methods education and training for SC CADRE investigators, undergraduates at SCSU,
and junior faculty at SCSU and MUSC-HCC. Additionally, the Biostatistics and Quantitative Methods Shared
Resource will expand the biostatistical research capacity at SCSU by hiring a full-time masters-level
biostatistician. In summary, this Shared Resource will act as a hub to facilitate the interaction among the SC
CADRE investigators, other shared resources, and SC CADRE undergraduates and junior faculty Scholars.